MECHANISMS OF INSULINS VASCULAR EFFECTS IN INSULIN DEPENDENT DIABETES

Endothelium dependent arterial relaxation in insulin-dependent diabetic patients will be assessed. To ascertain if EDRF Mediates insulin's vascular effect to increase blood flow and decrease vascular resistance.